Prediction error and motivated actions: Testing a specific mechanism of behavior in ecologically-valid contexts

PROJECT SUMMARY
Anhedonia is a common psychological symptom, of which the pathophysiological mechanisms are not clearly
understood. Moreover, anhedonia is a particularly difficult symptom to treat. The identification of underlying
mechanisms is therefore critical. Two core features of anhedonia are reduced motivation and impaired
reinforcement learning (RL). To date, however, these two components of anhedonia have been largely studied
in isolation. This is somewhat surprising, as both motivation and RL are known to engage a common network of
neural substrates, including the ventral striatum, mesolimbic dopamine, and the dorsal anterior cingulate (dACC).
Indeed, one proposed mechanism by which both motivational and RL deficits may arise is an abnormal neural
encoding of prediction error (PE), a signal with which the brain updates expectations about the value of future
outcomes. Specifically, disruptions in PE signals may lead to inappropriate updating and underestimation of the
value of effortful actions, thereby leading to reduced motivation. Therefore, the goal of this proposal is to test the
hypothesis that disrupted PE signaling may impact motivated behavior. A key limitation of prior work in this area
is that traditional behavioral paradigms assessing motivated behaviors have used simplistic and rigid trial-by-
trial structures that do not capture critical elements of motivated actions. Indeed, in lived experience, motivation
towards a goal emerges from a series of moment-by-moment decisions that occur as one interacts with the
environment. Therefore, more naturalistic paradigms and methods are needed. The PI will fill this gap in two
ways, by 1) examining the causal effect of disrupting PE signaling during a novel virtual-reality based paradigm
using inhibitory single-pulse transcranial magnetic stimulation to the dACC, and 2) testing the effects of a
behavioral manipulation of PE on motivation to engage in physical exercise in a two-week ecological momentary
assessment paradigm. This work is innovative because it uses novel, ecologically-valid approaches to study
motivated behavior and to causally-validate a specific neural mechanism for the integration of PE signals and
motivated actions. The significance of this work is that the role of PE signals in shaping motivated behaviors
could serve as a key mechanism underlying anhedonic symptoms, and a better understanding of its neural
circuitry could aid the future development of mechanism-based treatments for anhedonia. The PI has assembled
an interdisciplinary team that will help him to gain expertise in the neurobiology of anhedonia and advanced
computational modeling of human behavior. This project represents an excellent opportunity for the PI to develop
intellectually and professionally as an independent researcher.

Public health relevance
PROJECT NARRATIVE The proposed research will reveal neural mechanisms underlying motivated behavior assessed in ecologically- valid contexts. The goal of this research is to show that disrupted prediction error signaling impacts motivated actions, which could be a key mechanism underlying anhedonic symptoms. This work will further the missions of NIH and NIMH to identify pathophysiological mechanisms at the level of specific symptoms.